DP24-081 Michigan Screening and Intervention for Glaucoma and Eye Health through Telemedicine (MI-SIGHT) Program: A Pragmatic Randomized Trial

In the United States, seven million people live with visual impairment and one million live with blindness;
glaucoma is a leading cause of this visual disability. Black, Hispanic, Asian, and Native American people and
people with lower incomes bear a disproportionate share of the burden of glaucoma and vision impairment.
Though glaucoma is treatable, only half of people with the disease are ever diagnosed. Federally qualified
health centers (FQHCs) provide primary care for people who live in poverty. Because these people are
disproportionately of minority race and ethnicity, FQHCs provide care for people who are at higher risk of: 1)
having glaucoma and 2) not getting adequate treatment for glaucoma. There is a critical need to rigorously test
the effectiveness and cost effectiveness of innovative strategies to screen for glaucoma in high-risk
populations. The scientific premise of this proposal is based on the efficacy of telemedicine-based protocols in
identifying glaucoma and other eye disease at higher rates than national averages in high-risk communities
when run by academic medical centers. In this proposal, we will empower eye doctors at the FQHC – instead
of university physicians – to use telemedicine protocols to review digital, objective ophthalmic data captured by
local ophthalmic technicians to triage patients to appropriate in-person care, a 10-minute wellness visit or a 30-
minute detailed visit. The telemedicine protocols use advanced technology-based equipment not typically
found in FQHCs (e.g. optical coherence tomography, autorefraction). In this proposed telemedicine program,
ophthalmic technicians will also act as health care navigators to help people access low-cost glasses from on-
line retailers and access recommended medical treatment. Our objective is to test the effectiveness of this
comprehensive telemedicine-enhanced care approach compared to usual care (a comprehensive eye exam) in
glaucoma and eye disease screening and evaluate implementation and costs. We will conduct a Type 1
effectiveness-implementation hybrid randomized pragmatic clinical trial to test whether telemedicine-enhanced
care is more effective than usual care in 1) identifying glaucoma/suspected glaucoma, cataract, diabetic
retinopathy and macular degeneration and 2) improving vision-related quality-of-life one month after
participation. We will explore the impact of telemedicine-enhanced care on treatment of refractive error, patient
satisfaction, and completion of recommended follow-up care. We will use implementation science strategies to
identify and prioritize which barriers need to be addressed to implement evidence-based eye care at the local
FQHC after the trial. We will create a toolkit for implementation of evidence-based eye care at other FQHCs.
We will assess costs and model cost-effectiveness to compare the societal value of telemedicine-based
glaucoma and eye disease screening compared to usual care. This work will inform our long-term goal of
addressing striking and persistent inequities in eye health outcomes by leveraging the existing network of
FQHCs to provide high quality eye care.

Public health relevance
To decrease the prevalence of preventable blindness due to glaucoma, we need to: 1) screen high-risk populations with increased disease prevalence and decreased access to care and 2) support people who screen positive in accessing appropriate eye care. Federally qualified health centers exist throughout the US to provide care to medically underserved populations – the same populations who are at increased risk of glaucoma. Testing whether telemedicine- enhanced eye disease screening is more effective than usual care in detecting glaucoma at a federally qualified health center will inform best practices for scaling eye care at these health centers and ultimately, mitigating disparities in eye health outcomes.